Columbia Roybal Center for Fearless Behavior Change - Renewal

The goal of the Columbia Roybal Center for Fearless Behavior Change is to advance behavioral
interventions that reduce psychological distress and improve health behaviors in midlife and older adults that
experience serious health events. Each year, millions of adults experience events such as heart attacks,
strokes, or life-threatening cancer diagnoses. For some, these events serve as a wake-up calls, or “teachable
moments,” and those patients acquire health behaviors that prevent recurrent events and slow disease
progression. Yet, many of these patients are highly distressed after these events, leading to substantial impact
on quality of life, health behaviors, and prognosis. For example, 1 in 3 patients develop PTSD symptoms after
cardiac arrest and critical illness, and 1 in 5 patients develop persistent depressive symptoms after heart
attacks. Those patients who are highly distressed are less likely to follow recommended health behaviors such
as taking medications, exercising, and having good sleep. We have shown that many patients avoid
medications because they are reminders of disease risk, and exercise because physiological changes (e.g.,
heart rate) are distressing reminders of the possibility of a recurrent event. Accordingly, our Roybal Center is
interested in advancing interventions that target these fear-based mechanisms for which interventions are
underdeveloped. There are already evidence-based interventions for reducing other common forms of
psychological distress after serious health events such as anxiety and depression. Our Center also aims to
conduct implementation research that accelerates the adoption of these effective interventions into practice.
Our Center will include a Behavioral Intervention Development Core that provides implementation science,
regulatory, and statistical support to trialists. In the first year, this Core will launch a Stage II randomized
clinical trial (N=90) testing a psychological intervention for PTSD (Acceptance and Mindfulness-Based
Exposure Therapy) that was that was previously developed and feasibility tested by our Center versus a
standard of care control (Present-Centered Therapy) in cardiac arrest survivors. This trial demonstrates our
capacity to advance interventions through the NIH Stage Model within our Center. In the first year, our
Center will also initiate a pragmatic cluster randomized trial (N= 50 clinicians; 200 patients) testing the effect of
an implementation strategy (a digital patient activation tool) versus usual care on the uptake of evidence-based
treaments for depressed patients with recent CVD events. This trial illustrates our Center’s capacity to
conduct Stage V research. Our Center will also include an Administrative Core responsible for soliciting
proposals for new trials consistent with our Center’s theme via a national competition. This Core will
collaborate with NIA’s Stress Measurement Network and Science of Behavior Change program to ensure
robust measurement of behavioral mechanisms in all trials. It will also oversee trials; disseminate findings;
promote DEIA in trial conduct; develop collaborations; and nurture the next generation of behavioral trialists.

Public health relevance
Project Narrative Most adults will experience serious health events in their lifetime, and these events will commonly result in psychological distress that impacts on quality of life and health behaviors that are needed to promote recovery and prevent recurrent events. Our Columbia Roybal Center for Fearless Behavior Change will advance mechanism-driven interventions that target psychological distress and assess whether better health behaviors result. Our existing research infrastructure inclusive of a common measures repository for mechanisms assessment, a standardized electronic assessment suite for behavior, implementation science expertise, and strong collaborations with patient stakeholders and scientific experts in the experimental medicine approach to behavioral intervention development will ensure that the trials conducted in our Center are well-positioned to yield impactful interventions.